BiOengineering Research Education to AcceLerate Innovation in STEM

BOREALIS - Abstract
”Engineering has a persistent diversity challenge,” states a recent National Academies report. The most
impactful science comes from diverse teams working together, and diversity in the STEM workplace improves
work engagement and performance, enhances the quality of research and provision of health care, and
promotes innovation. The current homogeneity in engineering, both regionally at Clarkson University (CU) and
nationally, motivates the BiOengineering Research Education to AcceLerate Innovation in STEM (BOREALIS)
Scholars program, and inspires Clarkson’s equity-minded approach to better engage sociodemographically
diverse regional students. To address these opportunities, BOREALIS is designed to recruit and enroll three
cohorts of five sociodemographically diverse students (including Black and Indigenous People of Color and
students with disabilities) especially from the rural, economically depressed North Country region of New York
State, and educate, encourage, and support them to enter the bioengineering workforce via pursuit of graduate
study in bioengineering. Students from the North Country often face challenges entering STEM fields and
building scientific identities, such as scant academic preparation, an unwelcoming atmosphere from faculty,
and navigating intersectionality of identities. Through a series of integrated and complementary educational
experiences—(1) a summer bridge program; (2) first- and second- academic year activities; and (3) summer
research experiences—combined with evidence-based mentor and mentee training, CU will foster BOREALIS
Scholars’ successful transition into and completion of the Honors Program, positioning them to pursue
graduate school in bioengineering or a related field. This new pathway leverages existing resources for student
success. The research education plan includes new initiatives for student success during the first
undergraduate years, and faculty training in and use of inclusive pedagogy and effective mentoring. The
BOREALIS Scholars program at CU represents one small step towards maintaining America’s scientific
leadership by investing in sociodemographically diverse students from the North Country. By the conclusion of
the project, we will have: (1) created an evidence-based mentored portal and pathway for research-curious
students to explore biomedical engineering early in their undergraduate career and (2) built and sustained
cohorts of sociodemographically diverse students from rural backgrounds engaged in biomedical science and
engineering research, leading to (3) an increase in the number of rural, diverse students pursuing
bioengineering graduate study. These three aims will enable our goal of increasing the number of rural, diverse
students pursuing bioengineering graduate school after CU.

Public health relevance
BOREALIS - Narrative The BiOengineering Research Education to AcceLerate Innovation in STEM (BOREALIS) research education program is designed to advance the diversity of the bioengineering research workforce by creating a pathway to bioengineering graduate study for regional, sociodemographically diverse students. Diversity in the research workforce enhances the quality of research and the provision of health care, and promotes innovation and growth—attributes essential for the public’s health and to sustain our nation’s preeminence in science.